Intravenously injected mesenchymal stromal cells protect against Acute Lung Injury by transferring mitochondria to restore endothelial function

PROJECT SUMMARY
Significance. Acute lung injury (ALI) is a major cause of mortality and morbidity, but a cure is still not
available. Recent preclinical studies show the potential for ALI therapy with bone marrow-derived
mesenchymal stromal cells (BMSCs). However, the BMSC protective mechanisms are incompletely
understood. Our goal is to define mechanisms regulating BMSC interactions with endothelial cells in situ to
define mitochondrial mechanisms responsible for protection against ALI.
Hypothesis. We propose the novel hypothesis that, in ALI, intravascularly (i.v.) administered BMSCs are
retained by selectin and Cx43-induced mechanisms leading to mitochondrial transfer to endothelial cells in
situ. We also propose that BMSCs protect against ALI by restoring mitochondrial function, resulting in the
reinstatement of the mitochondrial calcium uniporter (MCU) in endothelial mitochondria, re-establishing
mitochondrial Ca2+ buffering, and strengthening the endothelial barrier.
Specific Aims. The specific aims are to evaluate molecular mechanisms of BMSC attachment to lung
endothelium in situ (Aim 1), and to determine the barrier-protective effects of BMSC to endothelial
mitochondrial transfer (Aim 2).
Approach. We will achieve these aims by live confocal microscopy of mouse lungs, and precision cut slices of
mouse and human lungs. Our determinations will include (1) evaluation of selectins and connexin 43 in BMSC
attachment; (2) evaluation of mitochondrial transfer as the regulator of endothelial Ca2+ buffering by Ca2+
transit across the MCU; (3) quantifications of endothelial Ca2+, and live f-actin as barrier determinants; (4)
strategies for engineering BMSC mitochondria to enhance their efficacy after transfer.
Preliminary data. We show (1) BMSCs interact with and transfer mitochondria to endothelial cells in situ;
(2) ALI downregulates lung MCU and, thus, blocks Ca2+ buffering, causing endothelial Ca2+ increase and
endothelial barrier weakening; (3) Intravenously administered BMSCs rescue MCU, strengthen the barrier and
ameliorate ALI. These and other preliminary data on our measurement strategies support the feasibility of the
proposal.
Impact. This proposal will provide the first systematic interrogation of interactions between i.v. administered
BMSCs and endothelial cells of intact lung microvessels, as well as lung protective mechanisms subsequent to
BMSC mitochondrial transfer to the endothelium. Mechanisms relating the transfer to endothelial barrier
enhancement will be realized for the first time. Strategies for enhancing the efficacy of BMSC mitochondria
will be developed. The translational relevance of the hypothesis will be evaluated in human lung slices.

Public health relevance
PROJECT NARRATIVE This project aims to determine fundamental mechanisms by which intravascularly infused bone marrow- derived mesenchymal stromal cells (BMSCs) protect against acute lung injury (ALI). Specifically, the proposal addresses real-time BMSC interactions with lung endothelium in situ that cause BMSC mitochondrial transfer to endothelial cells of intact lung microvessels. We will evaluate the possibility that the transfer reinstates endothelial mitochondrial function and strengthens the endothelial barrier, effects that protect against ALI due to lung infection.